Investigating lipid phenotype as a metabolic adaptation to microenvironmental stress

Breast cancers emerge through a years-long process of somatic evolution within the physical constraint of milk
ducts, characterized by accumulation of heritable genetic and epigenetic changes. While these genetic
alterations have been extensively studied, less attention has been paid to the microenvironmental conditions
that select for these genotypes. We and others have demonstrated that evolving pre-cancerous hyperplastic
cells are subjected to spatio-temporal variations in oxygenation due to poor vasculature, acidosis due to
fermentative metabolism, and nutrient scarcity due to competition among cancer cells and between cancer and
stromal compartments. Adaptations to these microenvironmental stressors are prerequisite for survival and
eventually results in selection of cells with more aggressive phenotypes. To model the eco-evolutionary
dynamics of tumor microenvironment (TME) in vitro, we subjected benign breast cancer cells (eg. MCF7 and
MCF10AT) to harsh conditions encountered in TME (ie nutrient deprivation, hypoxia and acidosis resulting from
metabolism) and we observed that the cells that survive these selection pressures exhibited a lipogenic
phenotype characterized by robust accumulation of lipid droplets (LDs). We selected three nutrient stress
adapted clones (NSA) to further characterize the distinct metabolic phenotypes and to determine if this
phenotype switch contributes to aggressive tumor behavior. The selected clones maintained the lipid phenotype
under nutrient replete, normoxic and normal pH culture conditions implying that this is a hard-wired metabolic
phenotype. Indeed, the nutrient stress adapted cells (NSA) were more migratory in vitro and highly metastatic in
orthotopic xenograft models, however, grew smaller primary tumors compared to control cells. We will further
characterize lipid phenotype of the NSA cells by assessing differential gene expression patterns that define
distinct metabolic pathways. Further, we will determine if these clones engage in alternate nutrient acquisition
pathways such as macropinocytosis, receptor mediated endocytosis and entosis to scavenge nutrients and use
them to generate lipids. We will employ stable isotope tracing as well as image-based assays (live confocal high
content microscopy using Opera Phenix) to define the mechanism of lipid accumulation in adapted cells. Finally,
we will perform metabolic profiling to measure oxygen consumption rate and proton production rate and
determine their ability to metabolize alternate fuels including lipids. Combining these approaches, we propose to
decipher the mechanism whereby microenvironmental stress-induced evolution results in hard-wired phenotypic
adaptations, represented by a lipogenic phenotype. At the end this study, we expect to have a more complete
and comprehensive understanding of the microenvironmentally-induced gene expression changes that occur
during carcinogenesis, and how these relate to hard-wired phenotypic profiles, such as the lipogenic phenotype
that contribute to cancer progression. A deeper understanding of this metabolic switch has potential to identify
novel therapeutic targets.

Public health relevance
Narrative This proposal attempts to unravel a major challenge in understanding cancer progression i.e., how microenvironmental stress in the primary tumor select for distinct metabolic phenotypes. Specifically, we will study how switching to a lipogenic phenotype confers metabolic advantage to stress adapted cells. We propose to decipher the relationship between microenvironmental stress-induced evolution that results in hardwired phenotypic adaptation represented by a lipogenic phenotype as an initiator of cancer progression.